Role of resident macrophages in type II responses and trained immunity

ABSTRACT
The importance of tissue resident macrophages for pathogen clearance and tissue homeostasis is beginning to
emerge. However, our understanding of the multifaceted roles these macrophages play in mucosal tissues such
as the lung remains incomplete. The lung is a very complex organ with specialized structures to allow for
adequate gas exchange. The pulmonary microenvironment is unique and has a direct and important influence
on the resident immune cells, especially macrophage populations. One of the most important function of
macrophages is to regulate type 2 inflammatory pathways during helminth infections and allow for the resolution
inflammation and tissue damage after the pathogen is cleared. The precise cellular and molecular mechanisms
that macrophage populations utilize to accomplish these critical functions in vivo are not well understood. We
recently reported the discovery of an interstitial subset of CD169+ lung-resident macrophages that are
transcriptionally and developmentally distinct from alveolar macrophages (AMs). These CD169+ interstitial
macrophages (IM) are primarily localized around the large airways in mice and humans and in close proximity
to the nerves in the bronchovascular bundle. Our work has shown that these nerve- and airway-associated
macrophages (NAMs) are tissue resident, and express high levels of immunoregulatory genes that are strongly
associated with type 2 immune responses under steady-state and inflammatory conditions. Nevertheless, the
role of NAMs in regulating type 2 immune responses is not well understood. Using the Nippostrongylus
brasiliensis (Nb) model our preliminary data shows that NAMs are critical for mediating type 2 immune responses
and tissue repair following infection. Furthermore, we have observed that NAMs in particular continue to increase
in numbers long after Nb is cleared, which suggests this macrophage subset may exhibit epigenetic changes
reflective of an important role in mediating trained immunity. Indeed, our studies show that as late as 6 weeks
after Nb infection mice exhibit remarkable protection from subsequent respiratory viral infections. Thus, the
overarching hypothesis to be tested in this proposal is that lung resident macrophage subsets, (in particular
NAMs) carry out distinct functions, and their unique positioning and remarkable gene expression profile make
them critically important for regulating type 2 immune responses and tissue homeostasis. Furthermore, in
response to pathogens that trigger a robust type 2 immune response lung resident macrophages exhibit
hallmarks of trained immunity that have important consequences for subsequent heterologous infections.

Public health relevance
Project Narrative Tissue resident macrophages play critical roles in maintaining immune homeostasis in mucosal organs. The mechanism of how these cells regulate this process during type 2 immune responses in the lung is not well known representing a major gap in our understanding. Studies in this application will attempt to bridge this gap and test the hypothesis that interstitial macrophage subsets in lung are critical for mediating type 2 responses.